Fluorescence Microscopy

In meeting the goals and objectives of FMIC, the center continues to:

-Service and maintain state-of-the-art equipment for unlimited access by intramural scientists.
-Provide investigator training in the use and analysis of fluorescence and optical-based techniques.
-Develop and optimize experimental protocols in collaboration with intramural scientists.
-Maintain and develop state-of-the-art analysis tools and protocols in collaboration with investigators
-Monitor and incorporate emerging fluorescence and optical technologies that will support the mission of NIEHS into FMIC.

During this fiscal year, FMIC has collaborated and supported 35 Principle Investigators from 7 branches/laboratories within the NIEHS DIR.

Some publications from this FY resulting from work in the center is listed in the bibliography below:

Bibliography

He B, Wilson B, Chen SH, Sharma K, Scappini E, Cook M, Petrovich R, Martin NP. Molecular Engineering of Virus Tropism. Int J Mol Sci. 2024;25(20). Epub 20241015. doi: 10.3390/ijms252011094. PubMed PMID: 39456875; PMCID: PMC11508178.

Moon S, Zhao F, Uddin MN, Tucker CJ, Karmaus PW, Fessler MB. Flotillin-2 dampens T cell antigen-sensitivity and functionality. JCI Insight. 2024. Epub 20241105. doi: 10.1172/jci.insight.182328. PubMed PMID: 39499901.

Radzicki D, McCann KE, Alexander GM, Dudek SM. Hippocampal area CA2 activity supports social investigation following an acute social stress. Mol Psychiatry. 2024. Epub 20241115. doi: 10.1038/s41380-024-02834-9. PubMed PMID: 39548322.

Alexander GM, Nikolova VD, Stöber TM, Gruzdev A, Moy SS, Dudek SM. Perineuronal nets on CA2 pyramidal cells and parvalbumin-expressing cells differentially regulate hippocampal dependent memory. J Neurosci. 2024. Epub 20241231. doi: 10.1523/jneurosci.1626-24.2024. PubMed PMID: 39740999.

Alexander GM, He B, Leikvoll A, Jones S, Wine R, Kara P, Martin N, Dudek SM. Hippocampal CA2 neurons disproportionately express AAV-delivered genetic cargo. bioRxiv. 2024. Epub 20241128. doi: 10.1101/2024.11.27.625768. PubMed PMID: 39651273; PMCID: PMC11623684.

Harris EP, Jones SM, Alexander GM, Kandemir B, Ward JM, Wang T, Proaño S, Xu X, Dudek SM. Fate (or state) of CA2 neurons in a mineralocorticoid receptor knockout. bioRxiv. 2024. Epub 20241130. doi: 10.1101/2024.11.29.626110. PubMed PMID: 39651204; PMCID: PMC11623668.

Savy V, Stein P, Delker D, Estermann MA, Papas BN, Xu Z, Radonova L, Williams CJ. Calcium signals shape metabolic control of H3K27ac and H3K18la to regulate EGA. bioRxiv. 2025. Epub 20250316. doi: 10.1101/2025.03.14.643362. PubMed PMID: 40161793; PMCID: PMC11952514.

Sueyoshi T, Petrillo MG, Jewell CM, Bortner CD, Perera L, Xu X, Aguayo FI, Diaz-Jimenez D, Robinson AG, Cook ME, Oakley RH, Cidlowski JA. Molecular interactions of glucocorticoid and mineralocorticoid receptors define novel transcription and biological functions. J Biol Chem. 2025:108488. Epub 20250408. doi: 10.1016/j.jbc.2025.108488. PubMed PMID: 40209952.

Lin YP, Scappini E, Mirams G, Tucker CJ, Parekh AB. CRAC channel activity pulsates during cytosolic Ca(2+) oscillations. J Biol Chem. 2025:108519. Epub 20250423. doi: 10.1016/j.jbc.2025.108519. PubMed PMID: 40280418.

Snyder RJ, Shankar U, Delker D, Soerianto W, Burdick JT, Cheung VG, Watts JA. Guanine quadruplexes mediate mitochondrial RNA polymerase pausing. BMC Biol. 2025;23(1):129. Epub 20250513. doi: 10.1186/s12915-025-02229-4. PubMed PMID: 40361112; PMCID: PMC12076976.

Baptissart M, Gupta A, Poirot AC, Papas BN, Morgan M. TENT5C extends Odf1 poly(A) tail to sustain sperm morphogenesis and fertility. bioRxiv. 2025. Epub 20250324. doi: 10.1101/2025.03.20.644152. PubMed PMID: 40196629; PMCID: PMC11974682.

Day CR, Yaşar P, Adedoyin G, Bennett BD, Chow CC, Rodriguez J. Altered cofactor recruitment and nucleosome dynamics underlie bisphenol A's impact on ERα-mediated transcriptional bursting. iScience. 2025;28(7):112864. Epub 20250610. doi: 10.1016/j.isci.2025.112864. PubMed PMID: 40678530; PMCID: PMC12268693.

Harris EP, Kandemir B, Jones SM, Alexander GM, Ward JM, Wang T, Proaño S, Xu X, Dudek SM. Mineralocorticoid receptor knockout alters hippocampal CA2 neurons to become like those in CA1. Commun Biol. 2025;8(1):1037. Epub 20250710. doi: 10.1038/s42003-025-08378-0. PubMed PMID: 40640339; PMCID: PMC12246475.

Bird GS, Lin YP, Tucker CJ, Mueller G, Shi M, Padmanabhan S, Parekh AB. L-type calcium channel blockers at therapeutic concentrations are not linked to CRAC channels and heart failure. Clin Exp Hypertens. 2025;47(1):2515924. Epub 20250712. doi: 10.1080/10641963.2025.2515924. PubMed PMID: 40650434.

Stober VP, Trempus CS, Galdi F, Martin NP, Gladwell W, Cronce M, Cox JS, Keasling JD, Budzik J, Chen SH, Sakamachi Y, Li JL, McGee CA, Zaccaro DJ, Der JS, Tucker CJ, Scappini E, Campos Gomez J, Rowe SM, Cowman MK, Barkauskas CM, Lee PJ, Markovetz MR, Button B, Hill DB, Erxleben DA, Hall AR, Liu J, Xu Y, Pedone C, Antonelli-Incalzi R, Matalon S, Savani RC, Garantziotis S. Hyaluronan Ameliorates Viral Pneumonia in Mice and Humans by Inhibiting E2F1 Transcription Factor. Am J Respir Cell Mol Biol. 2025. Epub 20250728. doi: 10.1165/rcmb.2025-0173OC. PubMed PMID: 40720792.